Emotion regulation and self-regulation in older adults

DESCRIPTION (provided by applicant): Emotion regulation among older adults appears to be a relatively preserved capacity that is vital for wellbeing and successful aging. However, the limits of this ability and the circumstances under which older adults might be less capable of regulating their emotions are unclear. Furthermore, current theories that seek to explain how older adults regulate their emotions, such as increased allocation of resources for emotion regulation or improved efficiency of emotion regulation, have not been compared to each other. Therefore, the aims of the proposed project are to 1) test the limits of older adults'emotion regulation capacity and 2) gain a better understanding of how older adults use their more limited resources to regulate their emotions. These aims are part of a long-term goal of producing a scientific knowledge base for improving the emotional health and wellbeing of older adults. The proposed project will use a paradigm from the strength model of self-regulation that posits a limited, fatigable, and common pool of self-regulatory resources that are drawn on by any act of self- regulation-controlling one's thoughts, emotions, and behaviors-such that performance on a subsequent but unrelated act of self-regulation tends to be impaired. An equal number of older and younger participants will be randomly assigned to one of four experimental groups involving an initial activity that is high or low in self- regulatory demand followed by a dependent task of emotion regulation or attention regulation. Comparing the performance of older and younger adults on the dependent emotion regulation task will provide results relevant to Aim 1. The proposed project will also include resting heart rate variability (HRV), a physiological measure that may provide an index of self-regulatory capacity. Examining the relationships between performance on the dependent self-regulation tasks and HRV will provide a measure of the extent to which participants are allocating self-regulatory resources for the different tasks, results relevant to Aim 2. It is hypothesized that 1) older adults will perform better than younger adults on the emotion regulation task but worse on the attention regulation task, and 2) older adults will allocate more resources than younger adults for the emotion regulation task. The proposed project would yield valuable information about the limits of emotion regulation in older adults, provide more information about how older adults regulate their emotions, and generate hypotheses for future research about the potential costs and benefits of different self-regulation strategies and priorities in older adults. PUBLIC HEALTH RELEVANCE: The ability to control one's emotions is important for wellbeing, especially for older adults who experience declines in many other areas of physical and mental functioning. Older adults seem to maintain their ability to control their emotions well, yet the limits of this ability and the way they are able to do this is unclear. Therefore, this project seeks to test those limits and shed light on the strategies older adults use to control their emotions so that better interventions can be developed to improve the wellbeing and emotional health of older adults.

Public health relevance
The ability to control one's emotions is important for wellbeing, especially for older adults who experience declines in many other areas of physical and mental functioning. Older adults seem to maintain their ability to control their emotions well, yet the limits of this ability and the way they are able to do this is unclear. Therefore, this project seeks to test those limits and shed light on the strategies older adults use to control their emotions so that better interventions can be developed to improve the wellbeing and emotional health of older adults.